Elucidating the role of xanthine oxidoreductase in regulating muscle dysfunction in cancer cachexia

PROJECT SUMMARY
Cancer cachexia involves the accelerated loss of skeletal muscle mass and function which significantly reduce
patient treatment options, quality of life, and survival time. In addition to atrophy of myofibers, ectopic
accumulation of adipocytes between and within muscle tissues, generally referred to as myosteastosis, is a
distinguishing feature of muscle degeneration during cancer and its comorbidities which independently predicts
poor muscle function and prognosis. However, the exact mechanisms regulating myosteatosis during cancer,
and their relevance to muscle wasting, are unknown. Adipocyte formation in skeletal muscle is indicated to
result from the adipogenesis of a population of mesenchymal stem cells known as fibro-adipogenic progenitor
cells (FAPs) that reside in the muscle tissue microenvironment. Preliminary experiments using mouse models
of cancer cachexia and single-cell RNA sequencing revealed that muscles from tumor-bearing mice had more
adipocytes than non-tumor bearing controls, which coincided with an increase in FAPs expressing
adipogenesis promoting genes. One of the top-most upregulated genes in FAPs from cachectic muscle
encodes the enzyme xanthine oxidoreductase (XOR) which is known to be essential for adipogenesis in vitro
and in vivo. XOR is also known to be a major source of reactive oxygen species production that can activate
NF-B, a transcription factor that promotes muscle wasting during cancer cachexia. Therefore, this proposal
will seek to elucidate the role of XOR in FAPs to myosteatosis and muscle dysfunction during cancer cachexia.
In Aim 1, multiple mouse models of cancer cachexia will be used, in combination with Pdgfrα-CreER; tdTomato
and XORfl/fl mice, to determine if cancer promotes FAP adipogenesis through a XOR-dependent mechanism. In
Aim 2, in vitro and in vivo experiments will be conducted to determine if increased XOR activity in FAPs
contributes to NF-B activation in muscles during cancer cachexia.

Public health relevance
PROJECT NARRATIVE Skeletal muscle wasting and dysfunction during cancer are major contributors to disease burden and death. The research outlined in this proposal will increase our understanding of what causes these derangements and identify targets able to prevent/lessen their occurrence. This has potential for developing novel therapeutic strategies to improve patient treatment options, quality of life, and lifespan.